CLEC16A-driven regulation of astrocytes

PROJECT SUMMARY
Astrocytes are abundant cells of the central nervous system (CNS), with important roles in neurologic diseases
such as multiple sclerosis (MS) and its model experimental autoimmune encephalomyelitis (EAE). Although
mechanisms driving astrocyte pathogenic activities and subsets have been identified, less is known about the
mechanisms that suppress them. In preliminary studies aimed to define astrocyte-intrinsic regulatory
mechanisms we made the following observations: 1) A genome-wide CRISPR/Cas9 screen identified Clec16a,
which has been linked to MS in genetic studies1,2, as a suppressor of NF-kB- and NLRP3 inflammasome-driven
pathogenic astrocyte responses; 2) Genetic and pharmacologic studies established that mitophagy driven by
CLEC16A expressed in astrocytes (CLEC16AAST) limits the accumulation of mitochondrial products that activate
NF-kB and the NLRP3 inflammasome; 3) CLEC16AAST inactivation results in the worsening EAE and the
expansion of pathogenic ACLY+ p300+ astrocytes that display increased NF-kB activation and IL-1b production;
4) CLEC16AAST inactivation boosts microglial pro-inflammatory responses in EAE; 5) A CNS-penetrant NLRP3
inhibitor abrogates the worsening of EAE induced by CLEC16AAST inactivation; and 6) CLEC16A and mitophagy
are decreased in astrocytes in MS, while NLRP3 activation is upregulated. These are important findings because
most MS-associated genes have so far been linked to the control of immune cells, but not astrocytes. In addition,
mitophagy deficits in neurons, but not astrocytes, were previously linked to neurologic disorders. Finally, little is
known about the role of the NLRP3 inflammasome in the control of astrocyte responses and subsets. Based on
these findings, we hypothesize that CLEC16AAST limits NF-kB- and NLRP3 inflammasome-driven pathogenic
astrocyte responses in CNS inflammation. Thus, we propose to study the regulation of astrocyte responses by
this novel CLEC16A-NF-kB-NLRP3 inflammasome signaling axis. Specifically, we propose to: 1) Establish the
effects of CLEC16AAST on pathologic astrocyte responses in EAE and MS; 2) Perform transcriptomic and
epigenetic studies to define subsets of astrocytes and other cells controlled directly and indirectly by CLEC16AAST
and the mechanisms involved; 3) Use genetic barcoding and cell-specific gene perturbation approaches to
identify the effects of CLEC16AAST on astrocyte interactions with other cells and the mechanisms of cell-cell
communication involved; 4) Map the CNS location of cell subsets and interactions controlled by CLEC16AST using
in situ transcriptomics, immunofluorescence and single-cell RNA-seq datasets; and 5) Use CNS-penetrant
NLRP3 inhibitors in combination with CLEC16AAST deficient mice and astrocyte-specific in vivo CRISPR/Cas9-
driven gene perturbations to define the role of the NLRP3 inflammasome in the control of astrocyte responses
and subsets, and its potential for the therapeutic management of astrocyte-driven CNS pathology. In summary,
this project investigates the role of a novel CLEC16AAST-NF-kB-NLRP3 inflammasome signaling axis in the
control of astrocyte pathogenic activities and subsets, and its potential as a therapeutic target for MS.

Public health relevance
PROJECT NARRATIVE Astrocytes play important roles in central nervous system (CNS) physiology and pathology. Indeed, specific astrocyte subsets contribute to the pathology of neurologic diseases including multiple sclerosis (MS), but little is known about the control of disease-promoting astrocyte responses and their therapeutic targeting. In this project we use novel genomic and interactomic tools, animal models and clinical samples to investigate the regulation of pathogenic astrocyte responses and subsets in MS, and approaches for their therapeutic targeting.